MODE OF ACTION OF THYMUS DERIVED (T) SUPPRESSOR AND AMPLIFIER CELLS

The ability of spleen cells adhering to Vicia Villosa lectin to augment the magnitude of the antibody response to Type III pneumococcal polysaccharide (SSS-III) was investigated. The reactive cells appear to be more characteristic of amplifier T cells, than the contrasuppressor T cells described by other investigators.